Analysis of the recurrent Renshaw circuit

DESCRIPTION (provided by applicant): Knowledge of the organization and function of spinal systems is a critical need in developing therapies for motor dysfunction that accompany spinal injury and neurological disease. To achieve this goal, the longrange objective of this application is to determine how motoneuron pools are coordinated and regulated during motor activities. The specific aims of this application are based on the proposal that Renshaw recurrent inhibition regulates the activity of sets of motoneurons and associated la interneurons coactivated by common excitatory drives produced by spinal pattern generators. This possibility will be explored by testing two hypotheses. Studies for the first specific aim will test the hypothesis that rhythmic motor commands during locomotion and scratching are distributed to motor nuclei and their associated la reciprocal inhibitory interneurons. Experimental support for this hypothesis would establish a parallel distribution of rhythmic drive signals to motoneurons and associated la interneurons as a fundamental feature in the organization of spinal pattern generators. Studies for the second specific aim will test the hypothesis that rhythmic motor commands generated by spinal networks are organized to maintain separate excitatory drives to motor nuclei that innervate antagonist muscles and that are linked by la reciprocal inhibition. Reciprocal inhibition is a common feature of the spinal organization of motoneurons, la reciprocal inhibitory interneurons and Renshaw cells, yet spinal pattern generation can involve coactivation of motor nuclei whose muscles are mechanical antagonists as well as reciprocal activation. We propose that conditions for adequate control by these reciprocally inhibitory networks and the need for such adaptability in producing motor patterns are both satisfied by restricting motoneuron projections from individual sets of pattern generating neurons to pools that do not include these reciprocal inhibitory connections. The planned studies will provide fundamental information concerning the organization of spinal networks involved in pattern generation and motor control. In addition, the information obtained will provide insight into the roles that spinal mechanisms play in motor dysfunction following spinal injury and neurological disease and will help guide the development of therapies for the treatment of these disorders, such as the use of spinal cord stimulation following spinal injury.